Role of p66Shc in Regulation of Microvascular Reactivity of Renal Blood Vessels

Renal microvascular injury occurs in a majority of patients with diabetes and hypertension-induced
nephropathy. Thus, the uncovering of the molecular mechanisms of changes in microvascular reactivity of
renal blood vessels is necessary for developing new therapeutic strategies to combat these diseases, which
contribute significantly to escalation of health care. Based on our preliminary data we hypothesize that
overexpression of adaptor protein p66Shc is implicated in the loss of microvascular reactivity during the
progression of both hypertension-induced nephropathy and diabetic nephropathy. We will use genetically
modified Dahl salt sensitive (SS) rats, generated by targeted modification of Shc1 gene, and primary renal
vascular smooth muscle cells (SMC) derived from these rats. p66Shc-dependent regulation of microvascular
reactivity will be studied in rat afferent arterioles and human renal microvessels from deceased donors with
medical history of either diabetes or hypertension-induced nephropathy. Specific Aim 1 will test the hypothesis
that loss of renal microvascular reactivity in hypertension induced nephropathy is caused by p66Shc-
dependent inhibition of Ca2+ influx mediated by TRPC channels and will analyze molecular mechanisms of
TRPC regulation by p66Shc. We will test the role of p66Shc interaction with guanine exchange factor beta-Pix
in regulation of TRPC channels activity and channel subcellular distribution. Using 2-photon imaging we will
study the role of p66Shc in regulation of spontaneous intracellular Ca2+ oscillations in SMC embedded in the
vascular wall of human renal resistance vessels. We will also test compound SHetA2, known to interfere with
p66Shc action, for its ability to prevent p66Shc-induced decline of renal function in hypertension nephropathy.
The restoration of renal vascular function will be evaluated by studying microvascular responses to purinergic
activation and perfused pressure in the control SS rats and SS rats treated with compound SHetA2. We will
also define whether SHetA2 has beneficial effect on vascular function in samples from diseased donors with
and without hypertension. Specific Aim 2 will test the hypothesis that p66Shc regulates arteriolar KATP channel
activity and causes hyperfiltration in diabetic nephropathy. Effect of upregulation of KATP activity, in concert with
impaired Ca2+ influx responses to modulators of myogenic tone, is likely to promote vasodilation of renal
afferent arterioles, causing hyperfiltration. We will study whether p66Shc regulates KATP channels in human
renal microvessels. We will also employ type 1 diabetic rat model of STZ-induced diabetic nephropathy, which
display markers of the disease similar to those observed in human patients. p66Shc-dependent KATP channel
activity will be tested by electrophysiological recording in renal SMC. We will test whether p66Shc stimulates
KATP channel activity via inducing protein-protein interactions with adaptor protein 14-3-3. The proposed
experiments will provide direct evidence for the role of p66Shc signaling cascade in the regulation of renal
microvascular reactivity and progression of renal injury, associated with hypertension and diabetes.

Public health relevance
Renal microvascular reactivity is decreased in hypertension-induced nephropathy and diabetes. Based on our preliminary data we propose to test whether protein p66Shc suppresses microvascular reactivity of renal blood vessels, and whether inhibition of p66Shc action will prevent hypertension- and diabetes-related vascular dysfunction. Analysis of unique genetically modified rats and primary vascular cells, derived from these rats, will be combined with assessing vascular function of isolated rat and human renal microvessels in order to uncover signaling mechanisms causing loss of microvascular reactivity and provide novel targets for treatment of human vascular diseases.